Interventions to Reduce Infant Mortality and Morbidity in Low Resource Settings

This application provides evidence that the University of Alabama-Zambia Team has an
established record of major accomplishments in the Global Network, including leading the
design, implementation, and publication of single site and common protocol studies and clinical
trials. For the next 5-year cycle, three rigorously-designed multicenter randomized controlled
trials are proposed. The applicant and senior foreign investigator lead a research group
focused on clinical trials in Zambia and other low-resource settings. This group includes
obstetrics, gynecology, neonatology, general pediatrics, public health, and infectious diseases
specialists as well as midwives and research nurses who have worked together for 17 years
and communicate weekly. The foreign institutional support is provided by the University
Teaching Hospital, a partner during the last 17 years, which fully endorses this proposal. The
available population settings where our work has been conducted include the traditional Global
Network rural clusters, a large tertiary hospital delivery service, and a large set of urban delivery
first level facilities. The UAB-Zambia team members are well aware of the ethical and cultural
issues related to the conduct of research in Zambia and low-resource settings. The special
qualifications and unequivocal commitment of the Zambian investigators, as well as the full
endorsement of the Government of Zambia, University Teaching Hospital (Zambia), University
of Zambia, and the University of Alabama at Birmingham will ensure superior performance if this
site is granted participation in the Network. The long-term objective is to improve local health
care systems with education, training, implementation, and sustainability of programs to
decrease neonatal and maternal mortality, with the long-term goal of reduction of morbidities.

Public health relevance
More than 90% of deaths in children and pregnant women worldwide occur in low- and middle- income countries. This project is focused on the design, implementation, and publication of clinical studies aimed at reducing death and morbidities of pregnant women and their children in low- and middle-income countries.